GenePattern and GenePattern Notebook: Integrative 'Omic Analysis for Cancer Research

Project Summary
Over the past two decades, the landscape of cancer research has changed with the explosion of publicly
available and investigator generated datasets from evolving technology platforms, and the growing number of
sophisticated computational methods and tools to integrate and analyze them. To move the cancer research
agenda forward, the cancer research community needs a way to easily combine the right tools and methods to
analyze and visualize all the data relevant to their studies, and reproducibly capture the history of what they have
done. These objectives may be especially daunting for cancer biologists who don’t program. The GenePattern
computational genomics environment has served cancer investigators since 2004 and was enhanced by
GenePattern Notebook, released in 2017. The goal of this proposal is to continue to support, expand, and
enhance the GenePattern ecosystem. Through these efforts we will continue to support a diverse community of
users at the forefront of cancer research who seek to better understand the underlying mechanisms of disease,
translate improved methods for patient diagnosis and prognosis to the clinic, and identify new drug targets.
Aim 1. Ensure the GenePattern ecosystem continues to keep pace with new and emerging methods and
technologies and the changing cancer research environment. To increase the range of methods and
approaches available to the GenePattern community, we will provide seamless access to other popular ‘omic
analysis packages (Cytoscape, Galaxy, IGV) within GenePattern Notebook, allowing the interleaving of methods
from multiple packages within the same executable notebook. We will also provide support for querying and
accessing data hosted on selected cancer-relevant data repositories.
Aim 2. Continue to author and serve GenePattern notebooks for the cancer research community. We will
develop 30-50 new high utility notebooks for the GenePattern-Notebook Workspace, leveraging Aim 1 as
required, that provide users with guided, step-by-step execution of their integrative analysis. These will comprise
data processing and analysis workflows, including approaches that bridge the gap from discovery to translation.
Aim 3. Extend, maintain, and support the GenePattern ecosystem infrastructure. We will continue to support
and enhance the GenePattern ecosystem, including enabling hosting on multiple cloud architectures and high-
performance compute sites, and enhancing the Notebook user interface with high-value features.
Aim 4. Provide outreach, training, and support to our user community. We will engage the cancer research
community to continue to address their needs. A Scientific Advisory Board of cancer biologists and physician
scientists will review progress and guide our strategy as we proceed. We will continue our high level of support
and outreach for GenePattern and its notebook environment, including cancer-focused tutorials and training
materials, in-person workshops, conference presentations, webinars, and social media vehicles and our
responsive forum. We will fully participate in all of the ITCR program activities.

Public health relevance
Relevance GenePattern is a popular bioinformatics software ecosystem that puts sophisticated computational methods within the reach of all biomedical researchers to address a variety of problems at the forefront of cancer research, including patient diagnosis and prognosis, identification of new drug targets, and understanding disease mechanisms. We will continue to support and enhance the system by providing interoperable access to additional software tools and data resources from GenePattern Notebook, a beginning-to-end computational electronic lab notebook environment for combining analysis and text. Moreover, we will expand our collection of notebooks that provide cancer investigators with scientist-oriented cancer analysis scenarios and tasks for use in their own studies.